Innate allorecognition and KIR/LILR/HLA associations in kidney transplantation

Innate allorecognition and KIR/LILR/HLA associations in kidney transplantation
Kidney transplantation is a life-saving treatment for patients with end-stage renal disease. Despite
significant improvements in short-term renal allograft survival, long-term graft survival remains
suboptimal due to chronic rejection. We hypothesize that innate allorecognition - the sensing of
human leukocyte antigen (HLA) in the graft by killer Ig-like receptors (KIR) and leukocyte Ig-like
receptors (LILR) on recipient NK cells and monocytes – is a key driver of chronic rejection. We
propose to test the hypothesis by investigating associations between HLA/KIR/LILR genetic
variations and clinicopathological allograft outcomes in 2,000 donor/recipient kidney transplant
pairs derived from curated North American (Pittsburgh and San Francisco) and French (Paris and
Lyon) patient cohorts that are ethnically diverse. We will perform high coverage short-read and
HiFi long-read genomic DNA sequencing to obtain high resolution HLA and KIR/LILR typing,
respectively. The related KIR and LILR gene families reside adjacent to each other in a region on
chromosome 19 that spans <1Mbp. Low coverage whole genome sequencing will also be
performed to infer genomic ancestry, donor/recipient relatedness, and polymorphisms that
influence allograft outcomes. Finally, NK cell and monocyte analysis in blood and allografts will
be conducted on a subset of patients to gain mechanistic insights. The work will be executed by
a multidisciplinary team that includes experts from transplant nephrology, immunology, tissue
typing, pathology, and biostatistics & bioinformatics. The uniqueness of the proposal derives from
the high quality, long-term, clinicopathological data available for the cohorts; serially banked bio-
samples; accurate assembly of the KIR/LILR region through HiFi long-read sequencing;
concurrently available whole genome data; and the innovative scope of the proposal, which
extends the concept of allorecognition beyond T, B, and NK cells to monocytes. Information
gained could be readily implemented in the clinic to improve donor/recipient matching or patient
risk stratification and to provide genetic underpinnings for therapeutic targeting of innate immune
pathways in transplantation.

Public health relevance
PROJECT NARRATIVE Kidney transplantation is a life-saving treatment for patients with kidney failure. However, long-term survival of kidney transplants remains suboptimal due to chronic rejection. We propose in this grant application to perform DNA sequencing of critical regions of the human genome that influence the recipient’s immune response against the transplanted kidney. Knowledge gained will advance current methods of matching donors to recipients and improve our understanding of the mechanisms of transplant rejection.